Administrative Core

Project Summary
The Administrative Core (AC001) performs the centralized administrative functions for all 4 Research Projects
(P001-P004) and coordinates the activities of the Resource Cores (C001 and C002) and the Information
Dissemination Core (CD001). All components address the Overall Center Theme: Role of the Tetrapartite
Synapse in Risk for and Response to Alcohol Drinking. Scientific advice and feedback are provided by the
Program Advisory Committee (PAC), and executive decisions regarding Portland Alcohol Research Center
(PARC) activities are made by the Steering Committee. The Steering Committee sets and continuously
evaluates progress toward general scientific research directions and oversees quality control mechanisms in
all areas of Center activity. For example, the Steering Committee played a significant role in synthesizing
Center research results in the development of our current hypotheses regarding the extracellular matrix (ECM)
and its role in circuit function underlying drinking behavior. Additionally, they identified synergies between
continuing and new projects. The PAC evaluated our findings at a convened local meeting and provided advice
with regard to proposed research. Newly appointed PAC members assisted in the review of written PARC
components of the current competing application. AC001 will oversee genomics, bioinformatics and data
sharing, biostatistical analyses, and training and educational enrichment and outreach activities. It will
coordinate discussions among Core/Project PIs to facilitate hypotheses and data sharing, and direction
changes if needed, based on cumulative data. There are two lines of administrative responsibility within
AC001. The general administrative coordination of all Center activities and the Center's budget will be
supervised by Dr. Richards, the Center Director. The coordination of and future planning for scientific directions
will be supervised by Dr. Grant, the Scientific Director, with input from Dr. Richards, the rest of the Steering
Committee and PAC. Dr. Grant will act as Director in Dr. Richards' absence. Drs. Richards and Grant have
worked together on the Center for the past 10 years and formed a productive alliance in the development of
the current application.